p66ShcA in HIV associated Nephropathy

DESCRIPTION (provided by applicant): Human immunodeficiency virus-associated nephropathy (HIVAN) is a distinct clinico-pathological entity that is characterized by focal segmental glomerular sclerosis (FSGS) and tubulointerstitial lesions. Preliminary studies by others and us have indicated that many of the effects of HIV-1 infection are mediated via oxidative stress which results from the generation of reactive oxygen species (ROS). Recently, pivotal role of p66ShcA proteins have been identified in the generation of oxidative stress. The long term objective of the present proposal is to develop novel therapeutic strategies, targeting mutant genes or dysfunctional gene products, to arrest or prevent the development of HIVAN. Our recent preliminary studies in Tg26 (a mouse model of HIVAN) animals have shown that both glomerular and tubular cells showed enhanced generation of ROS. In addition, in in vitro studies, podocytes-transduced with HIV-1 not only showed enhanced expression of p66ShcA but also demonstrated increased generation of ROS; whereas, p66ShcA-deficient podocytes showed attenuated generation of ROS. Based on these results we hypothesize that in HIV-1 infection, inhibition of p66ShcA activates a Foxo3A- dependent stress program that promotes the survival phenotype. We further hypothesize that deletion of p66ShcA from the genome of Tg26 mice will not only attenuate or prevent HIV-1-induced oxidative stress, but also delay or prevent the progression of renal lesions. In the present proposal we will 7 Test the hypothesis that inhibition of p66ShcA in HIV-1-infected podocytes activates a Foxo3-dependent stress program that promotes the survival phenotype 7 Test the hypothesis that deletion of p66ShcA from the genome of Tg26 mice will delay or prevent the progression of renal lesions 7 Test the hypothesis that HIV-1-induced p66ShcA redox function and dysregulation of the mTOR pathway leads to renal pathogenesis associated with HIVAN The outcome of these studies will help us in the development of therapeutic strategies to treat this devastating renal disease.

Public health relevance
7. Project Narrative Patients infected with HIV-1 are prone to a rapidly progressing kidney disease termed HIV-associated nephropathy (HIVAN). There is high incidence of this kidney disease in young black African-American men. HIVAN is the third leading cause of End-stage renal disease among young black individuals, and is associated with the highest rates of hospitalizations in this population. At present, there is no specific treatment to cure this disease. Our long term research goal is to develop strategies to slow down the progression and/or cure of this devastating kidney disease.